Core D - Neuropath Core

Mount Sinai ADRC (Sano): Neuropathology Core (Core D) – Research Summary
The Neuropathology Core (NPC) at the Mount Sinai Alzheimer's Disease Research Center (MS-ADRC) is
dedicated to advancing Alzheimer's disease (AD) and related dementias (ADRD) research by providing
exceptionally well-characterized postmortem human brain tissue and related specimens. The NPC supports both
ADRC and non-ADRC researchers, contributing to the understanding of pathological mechanisms and the
development of biomarkers and therapies. The objectives are 1. To perform neuropathological evaluations and
conduct detailed diagnostic and research assessments using standardized and customized protocols, 2. To
maintain an ADRD-focused biorepository by operating a comprehensive biorepository of brain tissues, digital
whole slide images, and biospecimens, supporting broad research collaborations, and 3. To provide education
and cross-disciplinary support by offering specialized training and research support to educate the next
generation of neuropathologists and foster interdisciplinary research. This work is significant because NPC's is
essential for developing accurate ADRD diagnoses and understanding disease mechanisms. By supplying high-
quality tissues and data, the NPC enables the discovery of biomarkers and therapeutic targets. Educational
initiatives address the shortage of specialists and ensure the training of diverse and skilled researchers. This
work is innovative because the NPC leverages cutting-edge digital pathology and classical techniques to
enhance neuropathological assessments. Innovations include developing new diagnostic criteria, advanced
tissue processing protocols, and pioneering digital neuropathology approaches using deep learning and
computer vision. Our approach involves close collaborations, providing integrated support for autopsies, data
harmonization, biomarker validation, and genetic studies. The NPC's leadership from experienced
neuropathologists ensures the Core's effectiveness in supporting diverse research initiatives and fostering
community engagement.